Hypoxia, HIF, and Mucosal Inflammation

Tissue metabolism in ongoing inflammatory responses is an area of significant interest. Within the mucosa,
changes in metabolism are associated with shifts in availability of O2 and the expression of O2-sensitive genes,
particularly those regulated by the transcription factor hypoxia-inducible factor (HIF). As work in progress, we
have focused on understanding molecular pathways and functional endpoints initiated by the stabilization of
intestinal epithelial cell (IEC) HIF. These studies have revealed that diminished O2 availability (hypoxia) is a
major contributing factor to the resolution of intestinal inflammation. Studies from cultured cell systems, animal
models and human tissues have revealed that metabolites generated within the inflammatory
microenvironment are central to barrier regulation and anti-microbial function. Results from animal models of
intestinal inflammation have demonstrated an almost uniformly beneficial influence of HIF-1 stabilization on
disease outcomes, particularly related to the resolution of mucosal inflammation. Nonetheless, we believe that
there is significant untapped potential within this field of study. We hypothesize that HIF-1 and HIF-2-
dependent signaling evokes a pro-resolving epithelial phenotype during intestinal inflammation. Three
synergistic specific aims are proposed. In Aim 1, we will distinguish the select regulation of epithelial junctional
proteins by HIF-1 and HIF-2. Aim 2 will develop and test a new class of HIF prolyl hydroxylase inhibitors
(PHDi) on mucosal barrier function and wound healing. Specific Aim 3 will evaluate in vivo endpoints of
pharmacological HIF stabilization. Results from these experiments will provide new insights into innate
regulation of mucosal barrier and an expanded role for PHDi in the resolution of mucosal inflammation. It is our
hope that extensions of this will lead to the identification of new therapeutic targets for mucosal inflammatory
disease.

Public health relevance
Mucosal inflammatory diseases, such as Inflammatory Bowel Diseases (IBD), result in significant shifts in tissure metabolism that represent potential therapeutic targets. The proposed studies are designed to identify and test new inflammation-related metabolic pathways. Such studies should provide new avenues into our understanding of why inflammatory diseases develop, and in particular, how innate immune responses contribute to inflammatory resolution.